Patient Entered Data for Clinical Decision Support to Personalize Pediatric Asthma Management

PROJECT SUMMARY/ABSTRACT
This K23, Patient Entered Data for Clinical Decision Support to Personalize Pediatric Asthma Management, aims
to improve asthma management through enhanced, automated implementation of pediatric asthma guidelines.
The immediate goal is to gain skills and further training to understand methods to deliver effective clinical infor-
matics tools for asthma management. The candidate is an Assistant Professor of Pediatrics in the Division of
Pediatric Pulmonology at UCLA and a clinical informaticist. The candidate has assembled a nationally recog-
nized and experienced mentorship team to provide guidance and expertise in qualitative research, data integra-
tion, and implementation science. The training plan combines directed coursework to strengthen skills in these
areas; and tutorials with qualitative and health service implementation experts to gain the requisite insight and
hands-on experience needed for this project. Career training includes professional development seminars, key
scientific meetings, and coursework on grant writing to optimize future independent research funding.
The proposed research addresses the challenge practitioners have – and are currently unable to meet – to
incorporate the complex National Asthma Education and Prevention Program (NAEPP) asthma guideline ele-
ments in their asthma management plan. This study leverages patient entered data (via a patient portal) to create
a comprehensive, automatically generated guideline-adherent clinical decision support (CDS) tool. In combina-
tion with this patient-collected data, the CDS tool will use information from the individual’s electronic health record
(EHR) to recommend a pediatric asthma management plan to the healthcare practitioner at the point of care.
Critically, this study advances asthma management in the EHR by incorporating patient-reported data into the
information gathering workflow. Previous use of patient portals in decision-making has had low uptake, partially
due to usability issues and clinical workflow integration. Existing clinical decision support systems are often of
narrow scope and do not incorporate the entirety of guideline elements, including psychosocial and environmen-
tal factors. As such, the specific aims for this research are: 1) to develop and iteratively refine a user-friendly
patient portal interface and evaluate its ability to capture key elements of the NAEPP guideline; 2) to develop a
comprehensive CDS tool that integrates patient entered data; and 3) to pilot the CDS tool’s ability to capture
guideline elements in the clinical setting. By understanding qualitative and user experience design during the
development phases, we plan to launch a CDS tool that integrates seamlessly into end user tasks (both patient
and practitioner), helping practitioners execute a comprehensive asthma management plan for children in the
outpatient setting. An R01 application, planned to be submitted in Year 4 of this award, will evaluate the impact
of this patient portal/CDS tool using an RCT design.

Public health relevance
PROJECT NARRATIVE This research addresses the need for more personalized and comprehensive pediatric asthma management at the point of care in order to improve pediatric asthma management and outcomes. The studies will develop and evaluate a multifaceted clinical decision support system in the electronic health record that integrates patient reported data.